RENOVATIONS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Renovations are to upgrade and improve existing space to accommodate the Core facilities for the Center for Excellence in Diabetes and Obesity Research. These laboratories will house Core B: Imaging and Flow Cytometry, Core C: Cardiovascular Pathology, Core D: Animal Core Facility and Core E: Cardiovascular Imaging and Function. The renovations will include replacing all the original casework and rerouting the distilled water dispensers as needed, rewiring all the rooms to make them more functional for their current needs, installing new acoustical ceilings, upgrading lighting to current standards, and replacing the quarry tile floors with chemical resistant VCT flooring designed for lab use.